Surface Plasmon Resonance to Measure Biomolecular Interaction at Fresno State

PROJECT SUMAMRY/ABSTRACT
The Nicoya Alto is a surface plasmon resonance (SPR) instrument platform for measuring the kinetics and affinity
of protein-protein and protein-ligand interactions. SPR has become the standard approach for measuring protein
interactions and has broad applications in protein science and drug discovery. This instrument is capable of real-
time kinetic measurements using very low sample amounts. The long-term objective of this application is to
provide the infrastructure needed to measure biomolecular interactions at Fresno State. The users of this
instrument propose multi-disciplinary research and educational projects that measure protein interactions in a
range of applications including: antibody engineering, cancer drug discovery, anti-bacterial peptides, and protein
nanomaterials. The Nicoya Alto instrument will also be used in an educational capacity to train a generation of
undergraduate students in the fundamentals of protein structure relationships and quantitative binding. Fresno
State is a minority serving institution located in California’s central valley, we serve a population of
underrepresented minorities and 1st generations college students. Access to a state of the art- SPR instrument
will help the College of Science and Math’s serve this important student population and meet its strategic goal
of preparing the next generation of STEM professionals though innovation and discovery. The instrument will
bring new biomedical research capabilities to Fresno State, benefiting our diverse student population, enabling
the measurement of protein interactions in a variety of research and educational contexts.

Public health relevance
PROJECT NARRATIVE The Nicoya Alto is an advanced instrument capable of measuring protein interactions in real-time using a powerful technique called surface plasmon resonance. This instrument will enable researchers and students at Fresno State to study proteins for developing new cancer drugs, anti-bacterials, and nanomaterials. This new capability will help to train a new generation of scientists combing form the under-represented minorities found in California’s central valley.